Cancer Immunotherapy: Beyond Immune Checkpoint Blockade and Overcoming Resistance

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Cancer Immunotherapy: Beyond Immune
Checkpoint Blockade and Overcoming Resistance, organized by Drs. James Allison, Andrea Schietinger, Antoni
Ribas and Padmanee Sharma. The conference will be held in British Columbia, Canada from March 17–20,
2024.
Immune checkpoint blockade therapy (ICT) has provided lasting cures for a subset of patients with specific
cancers. Attempts to expand ICT toward other patients and cancers has revealed some of the limitations of ICT,
particularly as monotherapies. This meeting will discuss some of those limitations, touching upon lessons learned
from failed clinical trials, mechanisms of resistance to ICT, and new technologies which offer the promise of a
more comprehensive understanding of the tumor-immune response. A strong emphasis will also be placed on
exploring tumor-immunity beyond T cell biology. A better understanding of why immuno-oncology clinical trials
have failed in the past is expected to better inform basic scientists on design of pre-clinical studies that may
guide improved clinical trials that avoid the mistakes of the past. Further elucidation of the mechanisms through
which cancers are either refractory to initial treatment with ICT or gain resistance over time should provide
avenues to predict rationally designed combinatorial treatments from among the hundreds of thousands to
millions of potential combinations. Finally, new technologies, including high dimensional spatiotemporal imaging
and T cell engineering, provide new opportunities to expand our knowledge of immunology and therapeutic
repertoire sometimes in unexpected ways. This meeting brings together scientists and clinicians from many
aspects of tumor immunology to rethink the next steps in the evolution of cancer immunotherapy. It is expected
to provide a springboard toward basic science discoveries and new, more effective therapies.

Public health relevance
PROJECT NARRATIVE Cancer immunotherapy, a collection of approaches that coax patients’ immune systems to target cancer cells, has been a lifesaving advancement for certain patients and cancers. While many approaches in this area have shown remarkable effectiveness, the technologies do not apply to all cancers. This conference takes a “bedside- to-bench” approach that brings together clinicians and basic researchers from across academia and industry to take a critical look at clinical trial failures so as to glean insights that will guide novel research efforts to improve future cancer immunotherapy treatments and outcomes.